Self-Peptides Bound to MHC Class II in T Cell Selection

Abstract
Regulatory T (Treg) cells, serving as life-long guardians of the immune system, are distinguished by
constitutive expression of transcription factor (TF) Foxp3, playing a critical role in their differentiation, function
and fitness. Our previous studies showed that Foxp3 expression is stable in fully differentiated Treg cells,
while recently generated Treg cells can lose Foxp3 expression. Furthermore, Treg cell functionality and Foxp3
expression can be compromised in severe disease settings. Although the unresolved issue of resilience vs.
vulnerability of Foxp3-dependent Treg functional program is of major basic and clinical significance, presently
the role for Foxp3 protein in functional and transcriptional program of differentiated Treg cells in vivo remains
unknown. Our preliminary studies of induced degradation of Foxp3 protein in vivo using novel optimized Foxp3
auxin-degron model raise the possibility of a remarkable resilience of ‘mature’ Foxp3-dependent Treg cell
function and gene regulatory network (GRN) in adulthood, but not of ‘immature’ ones in early life. Based on
our published and preliminary studies we hypothesize that during Treg differentiation, initially vulnerable Foxp3
dependent GRN approaches a temporally self-sustained (attractor) state over a surprisingly long timescale due
to a requirement for persistent Foxp3 activity for this ‘maturation’. Upon assumption of this state, its resilience
ensures extended stability of Treg function even upon the loss of Foxp3 expression. In this proposal we will
test this hypothesis by elucidating Foxp3 GRN underlying Treg cell function, dynamics of its establishment and
its resilience to Foxp3 loss in physiologic and inflammatory settings using genetic gain- and loss-of-function
approaches. The following Specific Aims will be pursued: 1) elucidate a role of Foxp3 in the functional program
of Treg cells and its resilience in early life and adulthood under physiologic conditions and upon inflammatory
challenges; 2) investigate dynamic of Foxp3-dependent regulation of gene expression and chromatin in Treg
cells using chemogenetic gain- and loss-of-function approaches; 3) elucidate mechanisms of resilience of
Foxp3-dependent gene expression and functional programs using CRISPR and CRISPRi/a Perturb-seq
approaches. These studies will provide mechanistic, gene-regulation level framework for understanding of Treg
cell differentiation and function in health and disease and inform novel approaches for therapeutic targeting of
Treg cells and development of adoptive Treg cell therapies for autoimmune and inflammatory disorders.

Public health relevance
Narrative Expression of transcription factor Foxp3 is requisite for regulatory T (Treg) cell function indispensable for organismal health as demonstrated by fatal autoimmune inflammatory multi-organ syndrome resulting from Foxp3 deficiency. Defective Treg cell function has been suggested to contribute to pathogenesis of both mono- and polygenic disorders. Investigation of molecular and genetic mechanisms of Foxp3 regulation of Treg cells in early life and adulthood and its resilience proposed in this application will be indispensable for targeting these cells for treatment of a variety of autoimmune and inflammatory disorders and cancer, and for developing novel cell therapies for autoimmune, inflammatory, and degenerative disorders using genetically engineered Treg cells.